Novel Electrochemical Bandage for Treatment of Wound Infections

PROJECT SUMMARY/ABSTRACT
Biofilm bacteria cause two-thirds of infections in modern clinical practice, including wound infections. Host
defenses and most available antibiotics are inactive against biofilms, rendering the infections they cause
challenging to treat. Given the failure of antibiotics in management of biofilm-associated infections, novel and
innovative approaches are needed. Avoiding antibiotics will also decrease the dysbiosis and selection of
genotypic antibiotic resistance linked to their use. Our team, which includes microbiologists and animal and
human researchers at Mayo Clinic, alongside electrochemists and biofilm engineers at Washington State
University, is developing novel, mechanistically precise, potentiostatically driven electrochemical anti-biofilm
devices for wound infection prevention and treatment, and promotion of wound healing, which we call
electrochemical bandages (e-bandages). During the current funding period, we designed and constructed a
small prototype e-bandage controlled by a customized micropotentiostat that continuously generates non-toxic
concentrations of H2O2. We tested the H2O2-generating e-bandage in vitro and in mice. in vitro activity was
demonstrated against mono- and dual-species biofilms formed by 34 bacterial and 15 yeast isolates. The e-
bandage prevented and treated methicillin-resistant Staphylococcus aureus (MRSA) biofilms in a porcine ear
explant model and was then evaluated in vivo in a wound MRSA and/or Pseudomonas aeruginosa infection
model in mice where, compared to non-polarized or no e-bandage treatment, polarized e-bandage treatment
reduced bacterial counts in infected wounds, improved wound closure, and decreased wound purulence.
Based on success developing a small, H2O2-producing e-bandage and micropotentiostat to control its
operation, and demonstration of efficacy in treating wound infections in mice, we propose to scale up the
device to sizes suitable for human wounds of varying dimensions. We will confirm infection treatment and
wound healing activity and assess wound infection prevention in swine, and preliminarily evaluate safety on
healthy human skin. e-Bandages will be designed to conform to varying wound dimensions and geometries
while contacting uneven wound topologies to deliver H2O2 to the entire injury. We hypothesize that H2O2-
producing e-bandages will prevent and treat MRSA and P. aeruginosa infections and improve wound healing in
swine. We will preliminarily assess safety and tolerability of e-bandages when placed on normal human skin.
We hypothesize that H2O2-producing e-bandages will be well-tolerated by humans. Our goal is to have a
product ready for testing in human wounds at the end of our studies - that is, a product for infection prevention
and treatment, and promotion of wound healing. The innovative H2O2-producing e-bandage strategy provides
an original way to address wound infection prevention and treatment, avoiding conventional antibiotics and,
therefore selective pressure on commensal microbiota and emergence of antibiotic resistance.

Public health relevance
PROJECT NARRATIVE/LAY SUMMARY Microorganisms in biofilms cause a range of human infections and are resistant to most available antibiotics; further, antibiotic resistance, which is heavily influenced by the overuse of antibiotics, is a growing threat to human medicine. To overcome this challenge, we developed an “antibiotic-free” way to prevent and treat wound infections using electrochemically generated hydrogen peroxide, and operationalized our approach into a device called an “e-bandage” (short for electrochemical bandage). We showed that a small e-bandage controlled biofilms in the laboratory and in mice, and now propose to produce e-bandages of clinically relevant sizes and demonstrate efficacy in wound infection prevention and treatment and wound healing in swine, and safety on healthy human skin.